Predicting acute and dynamic suicide risk in rural sexual minorities

PROJECT SUMMARY/ABSTRACT
Sexual minority adults experience suicidal thoughts and behaviors (STBs) at rates 3–6 times higher than
heterosexual adults: Up to 20% of sexual minority adults seriously consider suicide each year, compared to 4%
of heterosexual adults. Sexual minorities are not a monolithic group, and STB prevalence varies by people’s
intersectional identities. For example, STB prevalence varies by rurality, such that rural sexual minorities have
higher STB prevalence than urban sexual minorities. Regardless of one’s identities, STB risk occurs in acute
and dynamic patterns. This means that STB risk changes quickly, over hours or days. Clarifying acute and
dynamic STB risk processes provides critical information on how to predict, prevent, and treat STBs. However,
there is a complete absence of research on sexual minorities’ acute and dynamic STB risk processes. This is a
critical barrier to progress in suicide prediction and prevention. In response to the NOSI for Research on the
Health of Sexual and Gender Minority Populations (MD-22-012), the goal of this K08 is to examine how acute
and dynamic STB risk processes predict future STBs in rural sexual minority adults. This K08 uses exploratory
sequential mixed methods to complete two studies and four research aims. In Study 1, Aim 1 will use
qualitative interviews to explore rural sexual minority adults’ perceived STB risk processes within and outside
rural and LGBTQIA+ communities. Qualitative data will inform assessments in Study 2. Study 2 includes a fully
remote ecological momentary assessment (EMA) protocol. The EMA protocol includes 6 surveys per day for
21 days, where participants will report on their STBs, known STB risk factors (stigma, low belonging), and the
risk processes identified in Study 1. Aim 2 will determine the feasibility and acceptability of rural sexual minority
adults completing a fully remote STB EMA protocol. Aim 3 will use EMA data to estimate acute, dynamic,
multivariate STB risk factor networks. Aim 4 will use STB risk factor network parameters to predict STBs at 3-
and 6-month follow-up. The research aims will provide pilot data for an R01 assessing the intersectionality of
sexual minority adults’ rurality, gender, race, and ethnicity on STB risk processes. To accomplish these
research aims, I will complete training activities related to four training aims: (1) develop expertise in sexual
minority health, (2) build skills in qualitative and mixed methods, (3) learn advanced EMA methods, and (4)
conduct person-specific data analyses. I will complete training activities under a team of expert mentors. The
scientific environment at the Pennsylvania State University and its College of Medicine offers ample scientific
and practical resources to successfully complete the proposed research and training aims and to achieve my
long-term career goal of becoming an independent clinical scientist. The proposed K08 will launch my
independent research career focused on clarifying intersectional STB risk processes for sexual minorities
across the rural–urban continuum and informing therapeutic targets for sexual minority STB prevention.

Public health relevance
PROJECT NARRATIVE Rigorous research is needed to identify mechanisms contributing to sexual minority health disparities, particularly from an intersectionality perspective. The intersectionality of geographic location and sexual orientation can profoundly impact prevalence of suicidal thoughts and behaviors, as rural sexual minorities experience disproportionate burden of suicidal thoughts and behaviors, often reside in high-stigma environments, and have limited access to healthcare resources. This project uses an innovative mixed methods approach to clarify acute and dynamic mechanisms underlying suicidal thoughts and behavior disparities among rural sexual minority adults and will inform therapeutic targets for suicide prevention in this uniquely high-risk population.